Interleaved 1H/23Na imaging for invasive and proliferative phenotypes of brain tumors

Invasive and proliferative phenotypes are vital cancer hallmarks, and these phenotypes are distinguished
by the fact that invasive cells lead the path for dividing cells as the tumor grows. Glioblastoma multiforme
(GBM) treatments, specifically chemotherapies, fail because cancer cells invade and proliferate beyond tumor
boundaries. But neither phenotypes can be tracked with existing imaging methods. We will develop 1H/23Na
MRSI technology to differentiate and track these phenotypes, and which will have major clinical relevance.
Compared to normal cells, cancer cells possess unique chemical and electrical properties. Interstitial fluid's
acidity and salinity are crucial for cell survival. Many cellular mechanisms help regulate essential cellular
functions by maintaining hydrogen ions (H+) and sodium ions (Na+) in the interstitial milieu, which is saline and
near neutral pH. Research from us, and others, reveal that acidity and salinity of interstitial and intracellular
spaces are altered in cancer, e.g., sodium-hydrogen exchanger 1 (NHE1), which aids H+ efflux and Na+ influx,
is upregulated in GBMs and contributes to altered transmembrane ion distributions.
Research on GBM models reveals an acidic interstitial fluid, vital for reshaping the interstitial matrix for
cancer cell proliferation and to guide cancer cell invasion. Similar work on human-derived GBMs shows that
interstitial Na+ is also altered, but this change supports a depolarized cell membrane - vital for cancer cell
proliferation. These novel results suggest that the combination of interstitial pH (pHo) and transmembrane Na+
gradient (ΔNa+m) maps can help generate independent biomarkers of invasive and proliferative phenotypes.
While 1H-MRI with gadolinium agents tracks tumor size, we and others have shown that agents with other
lanthanides can be used for pHo mapping with 1H-MRSI and ΔNa+m mapping with 23Na-MRSI. These 1H/23Na
maps are currently obtained individually, requiring lengthy acquisitions with separate agent injections. To
explore the relationship between dysregulated pH and electrolyte imbalances regulating cancer cell invasion
and proliferation, pHo and ΔNa+m maps must be spatiotemporally compared during tumor growth/therapy.
Our goal is to test the hypothesis that invasive cells lead dividing cells as the tumor grows, and explore
how their patterns change with treatment. First, we will interleave 1H and 23Na acquisitions to enable rapid pHo
and ΔNa+m mapping with a single agent infusion. Next, proliferative and invasive maps from combination of pHo
and ΔNa+m maps will be validated in nodular vs. invasive patient -derived xenografts (PDXs) using IHC and
ICP-MS. For clinical relevance, we will test potential of NHE1 inhibitor as an adjuvant chemotherapy to improve
GBM outcome. We will compare pHo and ΔNa+m maps with two different therapies (i.e., first-line GBM standard
of care chemotherapy temozolomide alone vs. temozolomide + cariporide) to capture fates of invasive and
proliferative phenotypes in nodular vs. invasive PDXs.

Public health relevance
Treatments of malignant gliomas, including glioblastoma multiforme which are the most lethal, fail because cancer cells invade and proliferate beyond tumor boundaries. But neither phenotypes can be tracked clinically with existing imaging methods. We will develop fast 1H/23Na spectroscopic imaging technology to distinguish these phenotypes in parallel, which will have major clinical relevance.